Develop a novel therapy with immuno- and onco-targeting dual efficacies to treat the triple negative breast cancer

While with the recent breakthrough in immunotherapy, which has transformed into a standard
care for therapy in treatment of many advanced cancers, cancer remains as the second leading
cause of death. This is in part due to the efficacy of cancer immunotherapy is still limited in
treatment of most solid tumors and often associated with immunotherapy-related adverse events
with multiple tissues/organs autoimmune inflammation. Clinicians have attempted combinations
of cancer immunotherapy with either irradiation or chemotherapies to achieve synergistic efficacy
and reduce their toxicities. However, one of the obstacles is that many of the chemotherapeutic
drugs, if not all, often have immune toxicities, and their administration largely reduces the immune
cell frequency in the circulating blood, which consequently impairs antitumor immunity and
diminishes immune checkpoint blockade therapeutic efficacy. Another urgent need in cancer
therapy is to improve the therapeutic efficacy to target cancer stem cells, which drive cancer
inhiation, metastasis and recurrence. Therefore, it will be ideal to develop an antitumor strategy
with both chemo-targeting and immuno-activating therapeutic efficacy and also can target cancer
stem cells. Importantly, our recent publications and preliminary studies revealed that USP22
functions as an oncogene in tumor cells and inhibits immune surveillance. Genetic USP22
suppression inhibits cancer cell growth, impair cancer cell stemness and boost antitumor
immunity. The current application from Northwestern University (NU) and an industry partner, the
startup company ExoMira, with the service based support from a world-leading chemistry
company WuXi AppTec aims to develop IND-enabling study of a first-in-class medicine, USP22-
specific small molecule inhibitor, for the treatment of triple negative breast cancer.

Public health relevance
Project Narrative The current study aims to develop a revolutionized antitumor therapy with both immune- and chemo-therapeutic efficacy to treat a broad spectrum of human solid tumors.